Whole body single AAV microgene in canine DMD

Project Description
Duchenne muscular dystrophy (DMD) is a lethal X-linked muscle-wasting disease caused by dystrophin
deficiency. Adeno-associated virus (AAV)-mediated systemic microdystrophin (μDys) gene therapy aims to
treat DMD with a bodywide expression of abbreviated dystrophin. With the support from NIH, we have made
many important contributions to the development of AAV μDys gene therapy. We pioneered AAV μDys
therapy for DMD cardiomyopathy; we were among the first to show that AAV μDys therapy can improve
muscle force in the mouse model; we were the first to demonstrate the histological and physiological benefits
of AAV μDys therapy in a large dystrophic mammal (the canine DMD model) by intramuscular injection; and
we were the first to achieve successful bodywide AAV μDys therapy in the canine DMD model. In addition, we
discovered several domains important for μDys function, including the dystrophin nNOS-binding domain and
membrane-binding domains. These studies and the outstanding contributions from many other laboratories
have led to systemic AAV μDys trials in DMD patients by several biopharma companies and the recent
approval of an AAV μDys drug by the FDA. Despite encouraging progress, several important issues
surfaced in clinical trials. These include toxicity associated with high-dose systemic AAV delivery, low
efficacy and immunogenicity of current μDys constructs, and uncertainty of the longevity of the therapy. The
field is also hindered by the lack of a good method for predicting AAV performance in human muscle. The
canine model is the most established large animal model. It faithfully recapitulates human disease. We are a
world-leading laboratory developing DMD gene therapy in the canine model. We recently developed a
xenograft model for testing systemic AAV delivery in human muscle. In this renewal, we will leverage our
expertise in AAV μDys therapy, the canine DMD model, and the human muscle xenograft model to (1) address
whether the toxicity associated with the high-dose AAV administration can be attenuated with the newly
developed more potent myotropic AAV capsids; (2) determine whether myotropic AAV μDys therapy can result
in long-term therapeutic benefits in the canine DMD model; (3) identify the best-performing AAV capsids for
systemic gene therapy in human muscle, and (4) develop more potent, deimmunized next-generation μDys
constructs. Our studies will greatly advance AAV μDys gene therapy for DMD and reduce the disease burden
on patients, families, and society.

Public health relevance
Public Health Relevance Duchenne muscular dystrophy (DMD) is a life-threatening muscle-wasting disease caused by null mutations in the DMD gene, an approximately 2.4 mb gene that encodes dyslrophin. Adena-associated virus (AAV} mediated microdystrophin gene replacement therapy promises to ameliorate the disease and improve life quality. In this study, we will address the toxicity associated with high-dose AAV delivery, determine the best AA V capsids for human muscle, and develop the next-generation microdyslrophin vector.